The role of experience during the critical period for the development of vocal motor circuits

PROJECT SUMMARY/ABSTRACT
In species that learn vocalizations, social experience acts on genetically encoded
forebrain circuits to enable vocal imitation. Critical periods limit when this social experience can
influence the development and function of neural circuits required for vocal learning. In
songbirds, HVC is a necessary song neurocircuit component to form a song memory from the
social experience of hearing an adult vocal model (“tutoring”). Yet, HVC is also necessary as a
premotor region after the critical period. It is not well understood how the tutoring experience
acts on HVC to allow this dual sensory and motor function. Our single-nucleus RNA-sequencing
results demonstrate that the proportion of HVC’s projection neurons change throughout
development. During the sensory critical period, HVC neurons that project to the auditory region
and basal ganglia pathway are proportionally more than those that project to the motor pathway.
I hypothesize that HVC uses these distinct cell types to function as a sensory region early in
development prior to the maturation of its motor function. I therefore expect that the two former
projection neuron types experience the most genetic and electrophysiological changes related
to learning from the social tutoring experience compared to the latter projection neuron type. To
test this, I will examine single-cell epigenomic and transcriptional changes from tutoring
experience to measure changes in immediate early genes and genes related to plasticity and
learning. I will also use optogenetic circuit mapping to measure the changes in synaptic strength
from tutoring experience.

Public health relevance
PROJECT NARRATIVE Vocal learners, like humans and songbirds, require experience with adults of their species while they are young to learn and ultimately imitate their vocalizations, but how this early experience is encoded and interacts with circuits for vocal production is not well understood. The essential song learning and motor production nucleus, HVC, contains non-overlapping cell types that project to different regions. This research will elucidate if there are cell-type-specific genetic and synaptic changes in HVC that underly sensory learning and how learning from social experience interacts with motor circuits in HVC.